The Role of NAD+ Metabolism in Obesity-Induced Pancreatic Beta-Cell Dysfunction

Project Summary
One in every ten adults in the US suffers from Type 2 Diabetes (T2D), driven in part by an epidemic of obesity.
Currently, identifying a therapy to restore the population and insulin-secreting function of beta cells is the number
one unmet need in T2D. Our long-term goal is to reverse pancreatic beta cell failure to treat T2D. NAD+, an
energy-sensing metabolite and redox co-factor, is implicated to play a crucial role in determining the function and
survival of beta cells. Depletion of NAD, caused by inhibition of NAD synthesis or overactivation of NAD
consumers, leads to impaired insulin secretion and increased cytotoxicity in beta cells. Moreover, NAD booster
compounds show promises in improving insulin secretion in diet-induced obese mice. Our lab has recently
discovered that dihydronicotinamide riboside (NRH), a new and potent NAD booster synthesized by us,
significantly enhances insulin secretion and increases total insulin content in the pancreas of obese mice. Unlike
other NAD boosters, NRH is metabolized through a previously unrecognized NAD synthesis pathway and has
higher bioavailability in the pancreas. Our data suggest NRH acts by directly modulating beta cell NAD levels,
replenishing NAD content in pancreatic islets reduced by obesity. Based on this knowledge, our objective is to
uncover the mechanism of NAD depletion in obesity-exposed dysfunctional beta cells and identify metabolic
pathways through which NAD boosters including NRH can restore their functional mass. We will use mice models
of different T2D stages and human islets from healthy or T2D donors to define the correlation between beta cell
NAD content and their gradual functional loss. Primary mouse and human islets, beta cell lines, and mice with
different stages of beta cell dysfunction will be used to test two major aims. Aim 1 will define the changes in NAD
biosynthesis and degradation pathways in beta cells under obesity-induced deterioration towards T2D. Aim 2
will use an optimized NAD boosting strategy to rescue pancreatic beta cell mass and function in T2D models.
Completion of this project will provide new pathophysiological mechanisms driving beta cell deterioration due to
NAD depletion. These discoveries could revolutionize therapeutic approaches, offering NAD restoration in
pancreatic beta cells as new treatment strategies to not only prevent but also reverse the progression of T2D.

Public health relevance
Narrative Rescuing beta cells is a key unmet need in treating Type 2 diabetes, a condition affecting one in ten adults. Our proposal focuses on how NAD+, a metabolite crucial for beta cell function and survival, becomes depleted in beta cells with obesity. We will also explore the use of NAD boosting treatments, featuring a new NAD booster named NRH, to revive the function and number of beta cells, with the ultimate goal of developing better treatment for T2D.